Contrast-Enhanced/Microbubble and B-Flow/M-Mode Ultrasonography to Quantify Uteroplacental Perfusion During Baboon and HumanPreganancy

PROJECT SUMMARY/ABSTRACT: During human pregnancy, placental trophoblasts replace the smooth
muscle, vascular endothelial (VE) cells, and elastic tissue of the walls of the uterine spiral arteries (SA) within
the decidua basalis (DB), transforming these arteries into high-capacity vessels with distensible walls/enlarged
lumens to promote blood flow to the intervillous space (IVS) and fetal development. A defect in uterine artery
remodeling (UAR) underlies fetal growth restriction (FGR), preeclampsia (PE) and pre-term birth, which result
in neonatal morbidity/mortality. Non-invasive real-time methods to detect impaired UAR in the first trimester
would be highly advantageous to more effectively diagnose and treat PE, preterm birth and FGR. A major
limitation of widely used Doppler is that it does not reliably detect impaired UAR earlier than the second
trimester and is limited by “blooming” artifacts, aliasing, and signal dropout. We have shown that elevating
estradiol (E2) levels in early baboon pregnancy suppressed UAR and caused maternal VE dysfunction and
FGR. Our baboon translational model provides a novel experimental paradigm in which to establish real-time
imaging technologies to assess SA perfusion as an index of UAR. Contrast-enhanced ultrasonography
(CEU)/microbubble (MB) imaging is used to assess blood flow diagnostically in men and nonpregnant women,
but currently cannot be performed in pregnant women carrying to term. We propose that CEU/MB provides a
real-time acoustic snapshot of the volume/lumenal area of and flow within the SA as structural and functional
indices of UAR. Ultrasound B-flow is a 4D non-Doppler technology and we have for the first time
superimposed M-mode on B-flow to quantify with exceptional spatial resolution SA diameter and mural
distensibility. The overall goal of this study is to establish CEU/MB and B-flow/M-mode as novel prototypes to
quantify SA volume/flow and diameter/distensibility, respectively, as complementary structural and functional
indices of UAR across normal and abnormal pregnancy. Aim 1 will test the hypothesis that CEU/MB and B-
flow/M-mode provide state-of-the-art approaches to quantify SA perfusion and diameter/distensibility, as
indices of UAR, in baboons untreated or treated with E2 which suppresses UAR. Maternal, placental and fetal
physiological parameters will be ascertained in baboons after CEU/MB to establish safety standards for the
application of CEU/MB to human pregnancy. Aim 2 will test the hypothesis that ultrasound B-flow/M-mode
provides a novel method to quantify SA diameter/distensibility, as structural and functional indices of UAR,
across normal pregnancy and as an early marker of abnormal human pregnancy. Completion of this study is
expected to establish innovative imaging methods that will lead to more effective prediction and management
of adverse human pregnancy arising from defective UAR.

Public health relevance
PROJECT NARRATIVE The goal of this project is to establish CEU/MB and B-flow/M-mode as novel, powerful real-time imaging approaches to quantify spiral artery (SA) perfusion and dimension, as structural and functional indices of uteroplacental artery remodeling (UAR), during normal and abnormal nonhuman primate and human pregnancy. The experimental paradigm of defective UAR in a nonhuman primate provides an innovative approach to establish CEU/MB and B-flow/M-mode as imaging prototypes to assess uteroplacental development. Results from this study are expected to establish novel imaging technologies to quantify SA development across normal pregnancy and as an early marker of fetal growth restriction, preeclampsia and/or pre-term birth. This will facilitate the prediction and more effective management of adverse human pregnancy arising from defective UAR.